Community Partners

The central theme running through the center’s research projects and training program is consistent and robust communication across community partners and to and with mothers. Each community partner represents a node or access point to a larger web of community networks. These networks are necessary to garner community buy-in and engagement that amplifies community voices, needs, and resources. As liaisons, our community partners will ensure community member access to each stage of the center’s research projects and training program, including conceptualization, planning, execution, assessment, and dissemination. The first research project will develop and adapt an evidence-based community worker home visiting program that is grounded in extensive patient and community participation as well as partnerships with community organizations in healthcare, mental health, social work, and child/lactation support. The second research project will evaluate the effectiveness of a multilevel and multisectoral communication and health literacy strategy to increase trust and engagement in postpartum healthcare, through partnerships with community organizations. Supporting the goals of the research projects, an extensive research training program for early-stage investigators will address the factors that affect maternal outcomes, leveraging community partnerships with a consortium of academic and non-profit institutions supporting positive change in the Mississippi Delta. Aim 1: Establish a meaningful and equal community partnership throughout the entire research development and implementation process. Aim 2: Ensure transparency and trust by employing community-centric strategies for dissemination. Aim 3: Adjust and adapt the center through a community-based model to make a lasting contribution to women in the Mississippi Delta

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and maternal health disparities in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the factors that affect maternal outcomes. By establishing partnerships with the community in all parts of the process, we envision that this research center will overcome barriers to high-quality, relevant postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.